Demography and Ecology

Program Summary/Abstract
This T32 renewal application requests funds over five years to support six (6) predoctoral traineeships in
population research at the Center for Demography and Ecology (CDE) at the University of Wisconsin-Madison.
Since 1962, CDE has offered a world-class training program in population science, with nearly continuous
NICHD T32 funding since 1975. Our graduates are among the leaders in population research today, serving in
a range of academic, government and applied research settings. Guided by the NICHD mission “to ensure the
health, productivity, independence, and well-being of all people,” CDE research is organized around five major
areas: 1) Fertility, families & households; 2) the Demography of inequality; 3) Health and the lifecourse; 4)
Biodemography; and 5) Environmental and spatial demography. Our training objectives—and associated
research activities—fall squarely under the Population Dynamics Branch which “supports research, data
collection, and research training in demography, reproductive health, and population health.”
The primary goals of the CDE training program in demography are: (1) to foster an interdisciplinary
community of junior scholars in population research; (2) to build expertise in demographic theory, methods,
and analysis; and (3) to cultivate students’ professional skills, including the organization, execution,
presentation, publication, and critique of research. Within the CDE training program, the process of developing
this expertise involves four essential components: (1) formal training via coursework in students’ home
departments and interdisciplinary coursework in other departments; (2) exposure to cutting-edge research of
scholars in the broader community of population studies, primarily through the weekly Demography Seminar
(‘DemSem’); (3) participation and collaboration in substantive research projects of CDE training faculty through
an apprenticeship model; and (4) professional socialization and integration into the field of population studies,
especially via the weekly Demography Training Seminar.
Predoctoral T32 trainees are typically appointed in year 2 or 3 of their PhD program, having shown clear
academic promise and a strong commitment to pursuing a population research career; most students come
from Sociology, Economics and Population Health, although we are increasingly recruiting from a broader
range of disciplines. They typically receive T32 funding for two to three years. We are requesting 6 predoctoral
training slots (1 more than our current allocation) because our program has continued to grow in size, scope
and quality. Our training efforts have expanded to focus on interdisciplinary research areas at the forefront of
social science, especially biodemography and spatial/environmental demography, and we have been
successful at recruiting even larger numbers of highly-competitive students into our broader training program. A
critical mass of T32 traineeships ensures that we can continue to support our most outstanding students in
what we believe is one of the best available environments for predoctoral training in population research.

Public health relevance
Project Narrative The Center for Demography and Ecology at the University of Wisconsin-Madison offers outstanding and innovative training in demographic research, focused on the areas of fertility and families, inequality, health and the lifecourse, biodemography, and spatial and environmental demography. Our trainees pursue research careers across academic, government, and applied research settings. Their research increases our understanding of the behavioral, social, and economic processes that shape the health and wellbeing of the American population.